TGFβ Restricts Tfh2 Differentiation but Augments IgE-Mediated Mast Cell Function: Critical and Opposing Roles in Allergic Disease

T follicular cells (Tfh) act as effector helper cells that are critical in B cell class switching into IgE producing
plasma cells. Mast cells (MC) express the high affinity IgE receptor, FcεRI, that when complexed with IgE and
antigen, lead to degranulation and the release of preformed mediators irrevocably tied to anaphylactic
reactions. Learning more about Tfh and MC function and development can provide knowledge on new
therapeutic targets for unmet clinical needs. TGFβ is a complex cytokine that plays a well appreciated role in
the immune system, however the effects of TGFβ signaling disruption on IgE production and responses and
how this may impact allergic disease is still poorly understood. Given the potent and diverse role of TGFβ, a
better understanding of this pathway and its relationship to allergic disease pathogenesis is warranted. To
clarity this, we study Tfh and MC function in patients with Loeys-Dietz Syndrome (LDS), an autosomal
dominant disorder caused by mutations in TGFBR1 and TGFBR2, who are highly predisposed to food allergy,
asthma, allergic rhinitis and eczema. Using a mouse model of LDS with a knock-in allele (Tgfbr1WT/Mut ) of an
LDS mutation and patient samples, we found that LDS patients and mice have decreased lymphocyte
pSmad2/3 signaling downstream of TGFβ, increased Tfh2 cells, decreased Tfh17 cells, and increased food
specific IgE. LDS Tfh cells displayed a reduced STAT3 and SOCS1 signaling signature. Furthermore, LDS T
cells demonstrated increased PI3Kγ transcription and activity, which could be replicated with siRNA
knockdown of the TGFβ dependent transcriptional repressor, SnoN, and prevented with chemical inhibition of
PI3Kγ. In support, in vivo PI3Kγ blockage resulted in decreased Tfh accumulation and IgE production in
response to fed OVA antigen. Furthermore, LDS mice were unexpectedly protected from IgE mediated
anaphylaxis. In addition, cultured mice and human LDS MC’s displayed suppressed IgE-mediated
degranulation compared to healthy controls. Mechanistically, IL-33 responses were found to be enhanced in
LDS MCs, which was tied to decreased IgE mediated functions since LDS mice deficient in the IL-33 receptor
displayed a partially corrected anaphylaxis phenotype. Furthermore, transcriptome analysis revealed that the
neuropilin (NRP) signaling pathway was enhanced in LDS MCs. MC specific NRP1 knockout (cKO) led to
enhanced IgE driven anaphylaxis, suggesting a negative regulatory role for NRP1 in MC mediated IgE
functions. Therefore, this project will test the hypothesis that TGFβ signaling suppresses Tfh2 development via
PI3Kγ and SOCS1-STAT3 but augments MC IgE responses by blocking the negative feedback loops via
ST2/IL-33 and NPR1.

Public health relevance
TGFβ signaling plays a multifaceted role in immune cell regulation but its role in T follicular and mast cell development and function is unclear and its role in the joint regulation of both cell types is inadequately studied. We show that TGFβ signaling suppresses human and murine Tfh2 development to restrain IgE sensitization while promoting mast cell IgE anaphylactic reactions, demonstrating a divergent role of TGFβ in allergic diseases. This application will expand our work and delineate a mechanism for these observations.